Molecular Construct and Packaging Core

PROJECT SUMMARY – MOLECULAR CONSTRUCT AND PACKAGING CORE
The Molecular Construct and Packaging Core (MCPC) provides 1) molecular construct design and production;
2) packaging of Lentivirus and AAV vectors; and 3) repository, consultation, and training in molecular methods
to the UC Davis vision science community. The MCPC generates high-quality plasmids and viral vectors with
short turn-around times, efficiently and flexibly serving the project goals of our vision science investigators. By
being familiar with the needs and goals of individual labs, the MCPC also helps to promote collaboration and
cross-fertilization by encouraging the sharing of molecular reagents and knowledge between investigators with
similar needs or goals. Because this facility is the only such molecular or viral core facility at UC Davis, this
module provides essential support for cell and molecular biology approaches in the vision sciences.